Creation of a transgenic pig model permissive to HBV infection

PROJECT SUMMARY
The lack of a convenient animal model that is susceptible to hepatitis B virus (HBV) infection has prevented the
development of curative therapies for a disease chronically infecting over 300 million people worldwide. To
address the need for a universally applicable large animal model that can be used to advance understanding of
HBV biology and test curative strategies for chronic infection, the long-term goal is to establish an
immunocompetent pig model susceptible to HBV infection.
Prior studies have shown that the introduction of the HBV entry receptor, human sodium taurocholate
cotransporting polypeptide (hNTCP), into pig hepatocytes in vitro was sufficient to mediate HBV infection and
covalently closed circular DNA (cccDNA) genome formation. The central hypothesis is that pigs expressing
hNTCP will be capable of replicating HBV at high levels and subsequently will establish chronic HBV infection in
the liver with similar features to human patients.
To test this hypothesis, the efficiency of HBV infection and replication in pigs will be first evaluated in vitro and in
vivo. The proposing team, led by the PI, has previously established a method of non-viral endoscopic
hydrodynamic gene delivery into pig liver that greatly simplifies liver DNA delivery in vivo, supporting this first
aim. Using the knowledge from these experiments, the second aim is to create the transgenic pig model
expressing hNTCP that would be fully permissive to HBV infection. This will be accomplished by knocking hNTCP
cDNA into a safe harbor locus in the pig genome using CRISPR in fibroblasts, followed by somatic nuclear
transfer into embryos and implantation into female pigs. After gestation, transgenic pigs will be assessed for
hNTCP expression and normal physiology and biliary metabolism, and then tested for acute vs. chronic HBV
infection upon virus introduction, monitoring viral markers, immune responses to HBV proteins, and liver
pathological changes.
The innovation of the proposed research lies both in the (i) methods for interrogation of the most suitable DNA
construct to accomplish the overall objective and (ii) the final deliverable – a transgenic animal that is susceptible
to HBV infection, which is currently not available to the HBV field. The significance lies in providing a convenient,
immunocompetent pig model capable of authentic HBV to test novel HBV therapeutic strategies. Thus, the
proposed research benefits all, facilitating testing therapies stimulating HBV immunity toward the development
of a cure for chronic HBV infection.

Public health relevance
PROJECT NARRATIVE Hepatitis B virus chronically infects over 300 million people across the world, leading to cirrhosis, liver cancer, and death in a portion of patients. There is no cure for chronic HBV infection, and testing novel therapies is limited by the lack of animal models that can be infected with HBV. The focus of the proposed research is the creation of a pig model of chronic HBV infection, serving as a new HBV animal model that is universally applicable to developing and testing new HBV therapies.